Prefrontal Circuit Control of Isolation-Induced Aggression

PROJECT SUMMARY/ ABSTRACT
Extended deprivation of social contact can produce deleterious effects on the brain and behavior. Social isolation
(SI), or its perception (loneliness), is as predictive a risk factor for poor health outcomes as smoking or obesity.
Many factors have contributed to a modern epidemic of loneliness: a growing aging population, dramatic changes
to our social structure (technology, social media), the opioid crisis, and, most recently, the COVID-19 pandemic.
One of the most damaging impacts of SI is the promotion of interpersonal aggression and violence against others
– indeed, SI-associated domestic violence has risen by 20%, rates of suicide have surged, and school shootings
continue to rip at the fabric of society. Despite this, we have a poor understanding of the genetically-defined,
circuit mechanisms that give rise to isolation-induced aggression, representing a critical barrier for the
development of targeted interventions and cognitive therapies to treat pathological forms of aggression. One key
brain region known to exert top-down, cognitive control over behavior, including aggression, is the medial
prefrontal cortex (mPFC). However, the role of the mPFC in modulating the effects of SI-induced aggression is
unknown. In the project proposed here, we will interrogate the function of distinct, genetically-defined cells in the
mPFC to modulate SI-induced aggression. In support of this, we recently identified the neuropeptide Tachykinin
2 (Tac2)/Neurokinin B (NkB) as a key, subcortical mediator of SI. Here, we will test whether Tac2 signaling in
the mPFC exerts cortical control of SI-aggression. In preliminary studies, we have discovered that Tac2+ mPFC
neurons comprise a unique, unexplored class of GABAergic interneurons (INs). These findings lead to the
specific hypothesis that Tac2+ INs exert feed-forward inhibition of excitatory pyramidal neurons (PNs) to mediate
SI-aggression. To test this, we will combine behavior, machine learning, molecular-genetic loss- and gain-of
function manipulations, and in vivo Ca2+ imaging to achieve a circuit-level, mechanistic understanding of how
distinct populations of genetically-defined neurons in the mPFC exert coordinated, cortical control of SI-
aggression. We will determine whether mPFC Tac2+ neurons are required for SI-aggression (Aim 1), whether
mPFC PNs are sufficient to inhibit SI-aggression (Aim 2), and whether Tac2+ INs directly regulate PN activity
during SI-aggression (Aim 3). Collectively, we aim to uncover a conserved, genetically-defined mPFC
microcircuit for the top-down, cortical control of isolation-induced aggression. These findings will transform the
field by expanding our understanding of how pathological forms of aggression are encoded and controlled by
prefrontal circuits in the brain. Importantly, this research will have profound implications for the treatment of social
isolation-related mental health disorders, particularly those that result in violence.

Public health relevance
PROJECT NARRATIVE Prolonged social isolation can produce deleterious effects on the brain and behavior, including the promotion of interpersonal aggression and violence against others. The proposed research is relevant to public health, as we aim to achieve a circuit-based, mechanistic understanding of how the brain exerts coordinated, prefrontal control of isolation-induced aggression. These findings will transform the field by expanding our understanding of how pathological forms of aggression are encoded by the brain, and will identify targets for the treatment of isolation- related mental health disorders, particularly those that result in violence.